Artifact-free Micro-LED Optoelectrode for Multi-color Neuromodulation

Project Summary
Significance: While exploration of brain mapping has been moving forward at an unprecedented scale and
steady innovations in optogenetics have provided a toolset for identifying and manipulating of circuit
components, still electrophysiology tools for monitoring and perturbing targeted neurons in multiple local
circuits in the behaving animal are lagging. Understanding how local circuits perform in the brain requires high-
density recording from a statistically representative fraction of neurons and targeted cell-specific perturbation of
the circuit components. This grant application proposes to construct, test and disseminate micro-LED
optoelectrode platforms that meet these requirements for analysis of dynamic activity of neural circuits at
cellular resolution. Optogenetic stimulation gives effective means of high-accuracy circuit control with cell-type
specificity. The proposed approach is to directly integrate micro-LEDs close to the recording sites on each
probe shank. Neuron-sized lithographically-defined and monolithically-integrated LEDs allow scalable high-
density stimulation. Various configurations of fiberless, multi-color, multi-shank, multi-sites optoelectrodes will
be developed in a small form factor, comprising a micro-LED optoelectrode and driving/recording custom
integrated circuit chips assembled in a single printed circuit board. By placing circuits close the optoelectrode
probe, not only the noise can be significantly reduced but also the tethering can be simplified in a few wires,
allowing artifact-free high-density scalability, light weight and compact form factor. Also, the custom driver chip
can adjust the waveform for each individual micro LEDs, compensating possible variations in device
characteristics for precise control of optical stimulation and reducing any induced artifacts.
Preliminary Data: The previous work has demonstrated the feasibility of the optoelectrode that monolithically
integrated lithographically-defined micro-LEDs onto the neural probes using GaN on silicon. Recording of light-
induced neural activities has been observed with sub-microwatt illumination from each LED in the CA1
pyramidal cell layer. This selective local stimulation within very short distance enabled independent control of
distinct neurons in the intact brain of freely moving mice.
Specific Aims: In aim 1, high-density μLED optoelectrodes in different configurations for various animal
models will be designed and optimized for artifact-free neural modulation at cellular level. In aim 2, novel hybrid
integration technology will be applied to incorporate dual-color micro LEDs on the same shank at high density.
In aim 3, validation of the proposed micro-LED probes will be carried out by precision timing of neuronal spikes
for information processing in hippocampal circuitry.

Public health relevance
Project Narrative This project will develop and validate large-scale optoelectrodes for analysis of dynamic activity of neural circuits at cellular resolution in a behaving animal. The number of neuron-sized micro LEDs will be directly integrated on the probe shank close to high-density recording sites and further scaled up and extended to multi-color illumination to allow cellular resolution in cell-type specific stimulation. The developed tool will be validated in animal experiments to monitor temporal precision of neuronal assemblies in memory and differentiate neuronal responses to external inputs against intrinsic mechanisms, which is critical to understand and study neural disease and disorders.